Impact of Exercise Adaptations on the Aging Stem Cell

ABSTRACT
Aging causes cellular damage that leads to functional decline, chronic diseases, and ultimately mortality. Stem
cell functional impairment or loss is a significant effect of aging. To counter the effects of aging, intervention
strategies are being developed to refocus efforts on extending/enhancing the healthspan, i.e., the period of life
prior to the onset of chronic disease and disabilities of aging by maintaining good health. Endurance exercise
has long been held as an important lifestyle intervention to boost healthspan. However, the ability of chronic
exercise adaptations to affect signaling pathways that impinge on stem cell functions is unclear. Two key stem
cell populations—somatic intestinal stem cells (ISCs) and germline testis stem cells (GSCs)—serve as ideal
model cell types in Drosophila to determine the impact of exercise adaptations on the aging stem cell. Despite
their key similarities and differences in functional dynamics, both stem cell populations respond strongly to
JAK-STAT signaling, which, with aging, produces paradoxical effects on each population. In the ISCs, aging
increases JAK-STAT signaling and leads to a hyperproliferative phenotype resulting in gut dysplasia and
decreased healthspan. In the GSCs, however, aging leads to JAK-STAT hypoactivation and results in reduced
stem cell number and functional decline. Hence, aging perturbs the functional equilibrium for stem cell JAK-
STAT signaling. Using a Drosophila model of endurance exercise training, this project investigates the capacity
of exercise adaptations to ameliorate or even significantly prevent the deterioration of JAK-STAT signaling
dynamics in ISCs and GSCs, thus, furthering the healthspan of aging animals. Genetic approaches are
combined with morphometric imaging to determine the impact of exercise on aging ISCs and GSCs.
Furthermore, cell biological approaches complement unbiased, whole genome approaches—ChIP-Seq and
single cell transcriptomic profiling—to determine whether exercise adaptations can reset the gene expression
profiles and prolong normal functions in the aging stem cell. Together, these approaches are likely to uncover
results that are expected to enhance the understanding of fundamental molecular and cellular mechanisms
driving the impact of exercise on stem cell aging. These findings will have important implications for
translational approaches directed at investigating lifestyle intervention strategies to prevent aging-induced stem
cell malfunction.

Public health relevance
NARRATIVE This project will significantly contribute to our understanding of how exercise interventions impact stem cell aging. By using a multidisciplinary approach, we will uncover the key molecular complement and gene regulatory signatures affected by a conserved cell signaling pathway known for its role to mediate inflammatory responses. Determining how exercise modulates this pathway to render the purported benefits for aging stem cells is critically important for devising intervention strategies to combat aging-induced stem cell impairment.